Wnt signaling as a driver of pathogenic stromal inflammation in rheumatoid arthritis

Project Summary/Abstract
Fibroblasts are key aggressors in rheumatoid arthritis (RA) where they mediate cartilage and bone destruction,
yet treatments that directly target these cells are lacking. Recent studies from our group and others have
shown that the expansion of an inflammatory subset of fibroblasts are critical to perpetuating the chronic
inflammation in RA, but mechanisms responsible for their inflammatory potentiation are not well-defined. Our
preliminary studies have revealed that synovial fibroblasts are uniquely poised to signal through the Wnt
pathway and further demonstrate that Wnt induces a strong inflammatory response in these cells. Notably,
there is a striking transcriptional gradient demarcated by a Wnt enhancer, R-spondin 3 (RSPO3), and a
putative Wnt inhibitor, Dickkopf-related protein 3 (DKK3), that correlates with Wnt pathway enrichment. We find
that synovial fibroblasts derived from active RA patients show enrichment of gene signatures associated with
Wnt activation and Rspo3 expression, suggesting relevance to arthritis manifestation. We hypothesize that Wnt
signaling through this gradient is critical for mediating inflammatory fibroblast pathogenicity and that Wnt
inhibition can ameliorate joint damage in RA. We develop our hypothesis in three independent aims. In Aim 1,
we define the role of Rspo3 and Dkk3 in regulating Wnt-induced synovial fibroblast activation in vitro using
ligand stimulation and knockdown techniques. In Aim 2, we assess Rspo3 and Dkk3 regulation of Wnt
signaling in synovial fibroblasts of distinct RA patient clinical and histologic phenotypes. Finally, in Aim 3, we
evaluate the clinical utility of targeting stromal Wnt signaling therapeutically in mouse models of inflammatory
arthritis. We anticipate that the significance of these studies will be to elucidate a molecular mechanism
contributing to fibroblast pathogenicity in RA and to address the unmet need for fibroblast-specific therapeutics.
These studies will provide training in immunology, bioinformatics, and murine models of inflammatory arthritis
that that will build a foundation for the PI to develop an independent lab studying the role of stromal cells in
autoimmune disease.

Public health relevance
Project Narrative By elucidating a molecular pathway contributing to fibroblast pathogenicity in rheumatoid arthritis (RA), we hope that our research will impact patient care both diagnostically and therapeutically. First, our findings will provide therapeutic benefit by examining the potential role for targeting the Wnt pathway in RA and by helping to build a foundation for a new class of therapies that directly addresses stromal populations. Moreover, our investigation of Wnt signaling among early RA patients and patients who fail to respond to conventional therapies may lead to innovative strategies to categorize and identify patients who could benefit from targeted treatments.